BindingDB: An Open Knowledgebase of Protein-Small Molecule Interactions

Summary/Abstract
The present equipment request is designed to support the NIH-funded BindingDB project. The
equipment will make the BindingDB website and database faster and more reliable, so that
researchers can make optimal use of BindingDB’s massive data collection. The purpose of
BindingDB is described below.
Medications are organic compounds that bind specific proteins in the human body, and
researchers in universities, government labs, and pharmaceutical companies, are constantly at
work seeking such compounds. These ongoing efforts generate a continuous flow of information
about what small molecules bind what proteins, and how tightly. Scientists can learn from this
information and use it to guide the discovery of the latest generation of medications. However,
this information is typically published only in scientific articles or patents, where it cannot easily
be found or accessed by other researchers. BindingDB makes these data findable and far more
usable by extracting them from patents and articles and placing them in a web-accessible
database equipped with a range of search, download, and analysis tools. For BindingDB to be
maximally useful, this project also aims to maximize and, ultimately, certify, BindingDB’s
responsiveness, reliability, and trustworthiness. The requested equipment will strongly support
this aim.

Public health relevance
Project Narrative The BindingDB project helps scientists create new medicines by giving them easy access to a large collection of information about how drugs and drug-like compounds interact physically with the proteins in our bodies. The computer equipment requested in this supplemental proposal is chosen to make the BindingDB website and database faster and more reliable.